Racial/Ethnic Disparities in Housing Instability, Extended Kin Resources, and Late-Life Health

Project Summary
Housing is a critical social determinant of health and key contributor to racial/ethnic health disparities in the US.
In the context of rising housing costs, a recent recession, and the COVID-19 pandemic, experiences with
housing instability such as foreclosure, eviction, and homelessness are a serious and growing public health
concern. Black and Latino households are at an elevated risk of encountering these adverse housing
transitions compared with their White counterparts. Moreover, the subsequent exposures to heightened
psychosocial stress and financial strain have been shown to be particularly detrimental to Black and Latino
physical and mental health. Despite policy efforts to increase homeownership among Black and Latino
households, homeownership gaps remain large and have been widening. And given that homeowners are
more advantaged than renters, including having access to own household wealth and wealthier kin networks,
owners may be better equipped to sustain spells of housing instability over time and should be integral to
understanding how health disparities manifest later in life. Yet, we know little about the long-term health
consequences of housing instability, and how these stressful experiences contribute to racial/ethnic disparities
in late-life health. In addition, much of what is known about wealth and late-life health rests upon research
limited to Black-White comparisons, as well as work that has not considered the roles of extended kin financial
resources and adverse housing transitions. To remedy these issues, this project will leverage nationally
representative longitudinal data from the Panel Study of Income Dynamics (PSID) to evaluate a theoretical
model of housing instability and late-life health among Black, Latino, and White households. The unique
features of the PSID allow us to: (1) estimate the effects of housing instability on late-life health, and whether
the effects vary by racial/ethnic group and housing tenure; (2) determine whether racial/ethnic disparities in
exposure to housing instability mediate racial/ethnic health disparities later in life; and (3) determine whether
extended-family wealth moderates the effects of housing instability on late-life health, and whether the health
effects vary by racial/ethnic group and housing tenure. This project will complete these three aims using a
counterfactual framework that produces robust causal estimates of housing instability over time on late-life
health outcomes, including cognitive functioning, psychological distress, self-rated health, and functional
limitations. Estimates will come from marginal structural models with inverse-probability-treatment weights,
which will allow for time-varying confounders that overcome challenges facing conventional regression
techniques (e.g., selection bias, reverse causality)—a key innovation of this project.

Public health relevance
Project Narrative Evidence from this project will elucidate how experiencing housing instability over one’s lifetime can lead to worse health and disease later in life. Knowledge of how the negative consequences of housing instability for cognitive functioning, psychological distress, self-rated health, and functional limitations contribute to persistent racial/ethnic health disparities at older ages stresses to policymakers and health professionals the need for bridging housing policy with public health to meet the basic needs of disadvantaged, underserved individuals and communities.